Pacific Northwest Undiagnosed Diseases Network Clinical Site

Abstract:
The Undiagnosed Disease Network (UDN) works with participants who have undergone a long
diagnostic odyssey that has thus far not explained their medical condition. As a clinical site in
the network, we accept and evaluate participants while developing strategies to end diagnostic
odyssey’s. This requested supplement is an application for funds for activities not originally
planned. We are requesting additional time, through 6/30/23, to complete these aims. These
new aims are: Aim 1: Bear increased costs to accept participants from out of our original Pacific
Northwest area from 7/1/22 to 6/30/22. Aim 2: Enroll and evaluate new participants 3/1/23-
6/30/22 after the original planned and funded enrollment ends in February 2023, focusing on
recruitment of under-insured and otherwise medically underserved individuals. The overall goal
is to make the UDN accessible to more participants.

Public health relevance
Narrative: The Undiagnosed Disease Network (UDN) works with participants who have undergone a long diagnostic odyssey that has thus far not explained their medical condition. The overall goal of the current supplemental request is to make the UDN accessible to more participants.